Clinical Studies and LN FNA Core

CLINICAL STUDIES AND LN FNA CORE (CORE B)
CORE SUMMARY
The success of the entire program is contingent upon successful accrual of human samples. We are confident
in our ability to amass the necessary samples that will enable the most robust and compelling studies. The
Clinical Studies and LN FNA Core will provide a centralized resource for accrual of human lymph node (LN),
lung, peripheral blood mononuclear cells (PBMC) and plasma samples, and ensure the quality and uniformity
of handling of the samples received. These functions are crucial to provide a strong foundation for the studies
described in the three proposed projects. The Clinical Studies and LN FNA Core will work closely with the
individual Projects, the Administrative Core, the Sequencing and Epigenetics Core, and the clinical
subcontractors to enable success of all objectives in this program proposal. This Core will be responsible for
the preparation and maintenance of IRB protocols, oversight of subject recruitment, quality control of coded
clinical information and donor samples. The cohorts to be used for this program include samples from well-
regarded and successful collaborators and clinicians. We will work closely with Drs. F. Hasteh (UCSD) and S.
Yekezare (UCSD) and the Altman Clinical and Translational Research Institute (ACTRI) at UCSD to enable
acquisition of lymph node fine needle aspirate (LN FNA) samples for Projects 1, 2 and 3. We have a long-
standing collaboration with Dr. M.T. Brigger (Rady Children's, UCSD) to obtain tonsil samples to be used for
Projects 1 and 3. We also will collaborate with Dr. Ottensmeier (Southampton, UK) to obtain lung and lung-
draining lymph node tissue samples for Projects 1 and 3. LJI's in-house Clinical Core will manage the banked
samples from vaccinated individuals for Project 2 and will provide all new samples from pertussis- and yellow
fever virus-vaccinated donors needed for Projects 1, 2 and 3.